Development of a Sustained Release Injectable Formulation for Long-Term Delivery of ELQs

Project Summary / Abstract
The Medicines for Malaria Venture (MMV) recently published a “roadmap” for the types of medicines that are
needed to support the long-­term goal of malaria eradication. The roadmap consists of a wish list of target
candidate profiles (TCP) and medicines (target product profiles, i.e., TPP). With the most recent revision to the
anti-­malarial target candidates and product profiles the MMV highlighted the need for identifying new medicines
for chemo-­protection and chemo-­prevention with long-­acting molecules, and/or parenteral formulations (i.e.,
TCP-­2) (Burrows, JN et al., 2017, Malaria Journal, 16:26). According to their updated roadmap new drugs are
needed to protect populations entering areas of high endemicity during the final stages of malaria elimination.
And drugs with causal liver-­stage activity are needed for chemoprevention to prevent infection or outbreak of
resistance during malarial seasons. This TCP has been modeled on the combination drug atovaquone +
proguanil. The MMV envisions that an injectable sustained-­release formulation could be developed as a long-­
acting preventative providing up to 3 to 4 months of protection.
As a potent and selective inhibitor of the parasite’s cytochrome bc1 complex, ELQ-­300 targets Plasmodium
falciparum in the blood and liver stages and even kills parasites developing in the midgut of the mosquito vector.
With support from the NIH and US DOD we have been successful in developing an oral formulation of prodrug
ELQ-­331 for use in humans for weekly prophylaxis against malaria, work that was performed in collaboration
with SRI International. In the present application we seek NIH support for a comprehensive assessment of ELQ-­
300 prodrugs for intramuscular injection to effect the sustained-­release of drug from an oil depot (or other
extended release matrix) into the host bloodstream at levels above the minimum effective concentration needed
to block liver stage infection by infectious sporozoites. In collaboration with SRI International we will leverage
our knowledge of ELQ-­300 prodrug chemistry, crystallinity, stability, and solvent/vehicle solubility with their
expertise in formulation design and optimization to identify the optimal ELQ-­300 prodrug design that is paired
with an optimal depot formulation to provide long-­term protection of animals from sporozoite infection. Four
different prodrug chemistries will be evaluated and compared, varying R-­group chain length to optimize the
physiochemical properties of the drug and to enhance solubility in vehicles and mixtures that are approved for
human use. The overall goal is to develop a long-­acting sustained release formulation of an ELQ-­300 prodrug
for chemo-­protection against malaria.

Public health relevance
Project Narrative ELQ- 300 is a selectively potent inhibitor of the Qi site of Plasmodium falciparum cytochrome bc1 with activity against all life cycle stages of the parasite including liver, blood and vector stages. In this application we focus on the design of an ELQ- 300 prodrug for enhanced performance as a long- acting sustained- release depot formulation for intramuscular delivery and long- term chemo- protection against malaria.